Data and Repository Core

DATABASE AND REPOSITORY CORE – PROJECT SUMMARY/ABSTRACT
The specific aim of this Core is to support the establishment and management of a database and to manage a
biospecimen repository of individuals/families with new/atypical forms of diabetes. The database consists of
information provided on electronic case report forms by RADIANT enrollees, supplemental information from
their health care providers, laboratory and physical findings (including images) from a standard in-person visit,
whole genomic, RNA, and mitochondrial sequencing data collected over the three stages of the protocol. The
database also include metabolomics data on all enrolled participants. These data are augmented by
phenotypic and genomic interpretations provided by RADIANT investigators as new and atypical forms of
diabetes are studied.
The data management system developed for RADIANT utilizes a web browser user interface interacting with
an Oracle database backend. This approach is utilized on other multi-institutional settings and offers enhanced
functionality through minimal deployment effort, advanced user experiences and suitability for multi-institutional
or multinational use. The system emphasizes development of electronic interfaces from the laboratories or any
other electronic clinical record and, in such cases, no manual data entry is required. The application software
designed for data collection are primarily developed in Microsoft Integrated Development Environment utilizing
the Microsoft .NET Framework. The .NET Framework includes components such as ASP.NET, Web API,
Entity Framework, and JavaScript support. The main programming languages used to develop applications
include C#, JavaScript, and PL/SQL. The data are collected via interactive web interfaces, data uploads, and
XML/JSON formatted web services and APIs. Server-side services are used for dynamic data processing.
Data collected are primarily stored in an Oracle and SQL Servers databases. Data persistence is
accomplished with a combination of object relational frameworks and database stored procedures.
RADIANT also is building a biosample repository to support future testing, deeper phenotyping and the long
term goal of providing samples to the NIDDK Biorepository to be made available to the wider scientific
community. The biospecimen tracking platform, along with the RADIANT database, implements data
standards, terminologies, ontologies, models, and guidelines to the greatest extent possible and in compliance
with NIH direction. Data standards, terminologies, and ontologies exist throughout clinical medicine from
diagnoses to medications and laboratory identifiers. Leveraging these standards extensively will make
RADIANT data computable and classifiable while facilitating data sharing and integration.